Contribution of plasmablasts in the conversion of transverse myelitis to multiple sclerosis

PROJECT SUMMARY
Clinically Isolated Syndrome (CIS) patients experiencing their first neurological clinical episode related to Central
Nervous System (CNS) inflammation represent a unique opportunity to study the earliest immunological events
associated with CNS inflammation prior to treatment initiation. Our laboratory has acquired the largest human
sample repository of CIS patients experiencing their first clinical episode. Our preliminary data using state-of-
the-art cellular and genetic phenotyping demonstrate extensive B cell dysregulation within our untreated, CIS
cohort compared to controls including an expanded population of a B cell subtype called CD27high plasmablasts
in the cerebrospinal fluid (CSF) and peripheral blood at the time of their first documented clinical attack. In fact,
those patients with CD27high plasmablast expansion at the time of their first clinical attack were the only ones
who had documented exacerbations over the next two years. In addition, circulating CD27high plasmablasts
utilizing particular antibody genes tend to produce antibodies that bind neuronal antigens. These findings have
prompted us to question whether CD27high plasmablasts are involved in the autoreactivity associated with this
subset of CIS patients at high risk to convert to MS at the time of their first documented clinical attack. We are
also investigating whether Radiologically Isolated Syndrome (RIS) patients, who display CNS inflammation
similar to CIS patients but without clinical symptoms also exhibit expansion of CD27high plasmablasts that
produce anti-neuronal antibodies. The focus of this project will facilitate new mechanistic insights into the
contribution of CD27high plasmablasts in early CNS inflammation.

Public health relevance
NARRATIVE Although B cells seem to be important in MS, we don’t really understand what their role is in the disease. We have discovered a dramatic expansion of recently activated B cells making antibody (called “plasmablasts”) in the peripheral blood and spinal fluid of patients experiencing a first clinical neurological episode that places them at high risk for evolution to Multiple Sclerosis. In this proposal, we will characterize in detail the contribution of expanded plasmablast populations to early brain inflammation from patients with clinically isolated syndrome who display brain inflammation and clinical symptoms and patients with radiologically isolated syndrome who display brain inflammation but not clinical symptoms.